Visuocortical Foundations of Development

PROJECT SUMMARY/ABSTRACT
The integrity of the visual system during infancy has been associated with later developmental
and cognitive outcomes, suggesting that visuocortical function plays a foundational role for
cognitive development. However, the development of the visual system is complex, and it is
unlikely that a single measure reliably predicts cognitive function. The proposed research will
assess the development and predictive value of infant visual function using a battery of tasks and
machine learning techniques in a longitudinal sample of infants tested at 6-, 10-, 14- and 18-
months of age. A vision screener and electrophysiological measures will be examined in relation
to concurrent and subsequent cognitive performance measured by the NIH Infant and Toddler
(Baby) Toolbox (NBT). Aim 1 of the proposed work is to characterize infant visuocortical function
and developmental trajectories using a battery of tasks that measure (1) Visual Evoked Potentials
(VEP), (2) frequency-tagged steady state Visual Evoked Potential (ssVEP), (3) occipitotemporal
oscillatory EEG activity (dominant rhythm (alpha oscillation), (4) Event-related potentials (ERPs)
in response to faces and objects, (5) refractive errors and ocular misalignments associated with
poor vision using the Welch Allyn Spot Vision Screener, and (6) the development of pupil size,
pupil distance, and eye gaze deviations. Models of development will be examined for each
measure to estimate trajectories of developmental change as well as the internal consistency and
trial by trial reliability of the EEG measures using Bayesian Hierarchical Linear Models (BHLM).
Aim 2 is to determine the extent to which reliable indices of visuocortical function predict
concurrent and later developmental outcomes using two different innovative data integration
models. To address Aim 2, visual processing measures (VEP, ssVEP, EEG, ERP, and metrics
from the Spot Vision Screener) will be used as predictors in statistical models that link them to
concurrent and future results from the NBT (Cognition, Executive Function, Language, Numeracy,
Self-Regulation, Habituation, and Reaction time). A combination of the BHLM methods and
Variational Autoencoders will be used to reduce the data into a subset of reliable predictors. The
short-term goal of the proposed work is to delineate the developmental trajectory of visuocortical
function across infancy and determine the predictive value of a battery of visual measures in
relation to concurrent and later cognitive processes. The long-term goal of the proposed work is
to establish a reliable and informative index of healthy visual development that captures
developmental complexity and can be widely applied in the future.

Public health relevance
PROJECT NARRATIVE The development of visuocortical function includes a complex interaction of neural maturation and visual experience that result in foundational supports for later cognitive abilities. Early and accurate detection of visuocortical function impairments requires the use of multiple reliable measures and advanced data reduction and analysis techniques not currently available. The proposed project will develop an index of healthy visual development that captures developmental complexity with the expectation that this index will be clinically applicable in the future.